Conduction cooled superconducting magnet for low cost, compact proton therapy systems

Superconducting magnets are required that enable large-bore, higher field magnets to be reduced in size, weight, cost and with improved cooling in medical equipment and systems applications. High Temperature Superconductors (HTS) provide the best options for advancing these systems to higher fields and operating temperatures that are attained with Liquid Helium ? free refrigeration, provided they can be made with the required form, strength, uniformity and current density (Je) into high current, flexible cables, and those cables wound into sufficiently small diameter, high field coils. Among HTS options, only the “1G” Bi2223 (Bi2Sr2Ca2Cu3Ox) oxide in silver (Ag), and with added reinforcement, can presently meet all the requirements for these kinds of large scale commercial magnet applications. Most recently, an extra strong and flexible 1G tape called Type NX, that is reinforced with a superalloy, has been developed and commercialized. Its availability now enables development and demonstration in this program of the feasibility of large bore (~1 m dia.), high field (8T to10T) coils, wound with an NX based cable that can be conduction cooled and operated at 20K, rather than liquid cryogen cooled to 4K, as is required with presently available Low Temperature Superconductors (LTS). In this Phase 1 SBIR program, we will establish and prove the technology for producing long lengths of flexible 2 kA(8T, 20K) cable with Type NX, and from these cables, producing 0.8 m inner diameter test and demonstration solenoid coils with key features for building on order 1 m diameter, high field magnet coils. As a first step, we will develop a cable design with 8 high strength Type NX 1G tapes as a baseline, along with length production capability. The tooling and wire handling, as well as machine settings and procedures for producing long cables will then be established, and cables produced for coil development. In the next step, relatively short lengths of cable will at first be used to establish coil winding procedures, and then produce coils with pancake and level wind configurations, all with a 0.8 m diameter base. These coils will be tested for both cable and constituent wire Ic’s in different cooling environments, as well as dimensions and cooling and heat transfer characteristics. As a final step, several coils will be produced with longer lengths of cable, and their properties tested, culminating in a coil with about half the radial build required to achieve 8 T at 20 K with 0.8 m diameter, and proving that a conduction cooled magnet suitable for commercial medical equipment applications is feasible by the combination of our cable and coiling techniques. When fully developed in a Phase 2 program, this advance will enable the practical production of much higher field, large bore magnets that can be operated in a conduction cooled mode, for example at 20K, and that are overall, quite compact and inexpensive to operate, with application in medical instruments and devices.

Public health relevance
Proton Therapy for treating tumor cancer is available to less than 3% of the patients that could benefit from it, in spite of its improved effectiveness compared to X-ray therapy options. Superconducting magnets are now required that enable Proton Therapy Systems to be reduced in size, weight, cost and with improved patient throughout in order for them to be accessible by many more cancer patients. High Temperature Superconductors (HTS) provide the best options for advancing these systems to operating temperatures that are attained with Liquid Helium (LHe)-free refrigeration, provided they can be made with the required from, strength, uniformity and current density (Je) into high current, fexible cables, and those cables wound into sufficienty small diameter, high field coils. Analysts forecast global Proton Therapy Systems treatments per year to grow by about 12% annually for the next 10 years from about 60,000 in 2017 to about 210,000 in 2027, driven largely by the sales of Proton Therapy Systems with reduced sizes, weght and costs, with the assumption that developments with superconductors will lead to continued advances with Protom Therapy systems. Solid Material Solutions plans to develop and sell products into this market. Among HTS options, only the “1G” Bi2223 (Bi2Sr2Ca2Cu3Ox) oxide in silver (Ag), and with added reinforcement can meet all the requirements for large scale proton therapy applications. It is the most commercially developed HTS conductor, available at lowest cost, in km piece lengths and with excellent uniformity in properties. Most recently, an extra strong and flexible 1G tape called Type NX, that is reinforced with a superalloy has been developed and commercialized. Its availability now enables development and demonstration in this program of the feasibility of compact (~1 m dia.) high field (10T) coils, wound with an NX-based cable that can be conduction cooled and operated at 20K, rather than liquid cryogen cooled to 4K, as is required with presently available Low Temperature Superconductors (LTS). In the next step, an HTS-cable-based, conduction cooled coil must be developed with 1) a flexible, low cost, high- strength cable winding that enables 2 kA operating current at about 20 K (instead of at 4.2K), 2) field generated up to 10 T, and 3) compact size, for example, a solenoid bore with a 1m ? or less, or saddle coil with 1 m largest dimension. High current, long length flexible nominally 2 kA 1G HTS cable must be developed with: 1) the bend flexibility to wind ~ 1 m diameter coils with the Bi2223 in a fully reacted state, 2) the strength to support the tensile loads generated by the higher, up to 10 T magnetic fields that enable magney size reduction to <1 m, and 3) the current density required to wind compact, low cost coils. Solid Material Solutions (SMS) is developing cabled and coiled forms of Type NX HTS tape, as well as HTS wires with focus in this program on a first-of-its-kind, 2 kA high strength, flexible cable that is based on Type NX and that is wound into as small as a 0.8 m diameter coil with all the design features demonstrated to build a full scale coil for Proton Therapy magnet. As a first and most significant step, this program will prove the technology for producing long lenghs of flexible 2 kA(8T, 20K) cable with Type NX, and from these cables, producing 0.8 m inner diameter test and and demonstration solenoid coils with key features for building full scale Proton Therapy type coils. In the first part of this Phase 1 SBIR program, SMS will develop a cable design with 8 NX tapes as a baseline, along with length production capability. Cable critical currents, tensile load and bend tolerances, as well as dimensions, will be investigated and a cable design selected for coil development. The tooling and wire handling, as well as machine settings and procedures for producing long cables will then be established, and cables produced for coil development. In the second part, relatively short lengths of cable will at first be used to establish coil winding procedures, and then produce coils with pancake and level wind configurations, all with a 0.8 m diameter base. These coils will be tested for both cable and constituent wire Ic’s in different cooling environments, , as well as dimensions and cooling and heat transfer characteristics. As a final part, several coils will be produced with longer lengths of cable, and their properties tested, culminating in a coil with about half the radial build required to achieve 8T to 10T at 20 K with 0.8 m diameter, and proving that a Proton Therapy type of conduction cooled magnet is feasible by the combination of our cable and coiling techniques. As an additional level of verification, cable and coil samples will be provided to Varian Medical Systems– our collaborator on the development of HTS – based proton therapy magnets. When fully developed in a Phase 2 program, this advance will enable the practical production of higher field Proton Therapy Magnets that can be operated in a conduction cooled mode, for example at 20K, and that are compact, with an ~ 1 m maximum dimension or less.